HealthyCells: A Culturally-Tailored Smoking Cessation Smartphone Intervention for African Americans with Adjunctive Treatment for Sedentary Behavior

PROJECT ABSTRACT
Successfully increasing cessation rates among African Americans would reduce the racial disparity in mortality
between African Americans and Whites by up to 20%. Many smoking cessation interventions include physical activity
components to boost cessation rates, but no studies have attempted to promote sedentary behavior reduction as a
cessation strategy. Further, smartphones can facilitate intensive behavioral interventions without requiring burdensome
in-person treatment, and these interventions can be tailored to address the specific needs of African Americans and
capitalize on cultural strengths to reduce barriers and encourage behavior change. Our research team has developed
numerous smartphone interventions to address a range of modifiable health risk factors among vulnerable populations,
which are capable of being culturally tailored for African Americans. Of relevance to this research proposal, one is a
smartphone-based contingency management intervention that provides financial rewards for smoking abstinence after
remote verification of smoking status using low-cost portable carbon monoxide monitors and facial recognition software
(i.e., PrevailGO). The other is a smartphone-based sedentary reduction intervention that uses wrist-worn activity
monitors in combination with smartphone technology to monitor activity in real-time and deliver activity prompts when
individuals are engaged in prolonged bouts of sedentary behavior (i.e., SMARTpath). My long-term goal is to improve
smoking cessation outcomes among African Americans using evidence-based, culturally tailored smartphone
interventions. The overall objectives of this research proposal, which is the next step toward achieving this long-term
goal, are to (a) create a smartphone application for smoking cessation (i.e., HealthyCells), which will be achieved by
integrating two pre-existing evidence-based smartphone interventions, PrevailGO and SMARTpath, (b) create culturally
tailored treatment content (i.e., messages, images, and videos) for African American smokers, and (c) evaluate the
feasibility of HealthyCells at addressing smoking and sedentary behavior among African Americans. A pilot sample of
African American smokers (N = 15) will briefly use the HealthyCells app and provide critical feedback through semi-
structured interviews to refine the smartphone intervention. Once the HealthyCells app is refined, African Americans (N
= 30) who are interested in quitting smoking will use the app during a scheduled quit attempt. Starting on the scheduled
quit date, HealthyCells will prompt participants to complete twice-daily remote smoking status assessments to earn
rewards for abstinence. The app will deliver real-time messages telling participants to stand up and move around during
prolonged bouts of sedentary behavior (i.e., ≥ 30 minutes of uninterrupted time spent in a sitting, reclining, or lying
posture). Participants will also have on-demand access to culturally tailored information and strategies for remaining
abstinent and reducing sedentary behavior within the HealthyCells app. The primary outcomes will be biochemically
confirmed point prevalence smoking abstinence at 8 weeks post-quit date, and the difference in sedentary time 7
consecutive days before quitting compared with 7 consecutive days at 8-weeks post-quit, as measured by a research-
grade accelerometer.

Public health relevance
Public Health Relevance Section This K01 proposal details the development of HealthyCells—an evidence-based smartphone intervention for smoking cessation with adjunctive sedentary-behavior reduction—culturally tailored for Black or African American smokers. Although several in-person cessation programs exist for this group, scalable mobile interventions are scarce. By leveraging smartphone technology, this project offers an innovative, modern approach to reducing tobacco-related health disparities among Black or African American smokers.